Mechanism of calcium potentiation of alpha7 nicotinic receptors

PROJECT SUMMARY- α7 nicotinic receptors are widely distributed throughout the human brain, and are enriched in regions required for cognition, sensory processing, attention, working memory and reward. They have been implicated in neurodegenerative diseases such as Alzheimer’s and Parkinson’s and psychiatric diseases such as schizophrenia, and disorders of attention and cognition. α7 receptors are also present in non-neuronal cells where they contribute to a variety of anti-inflammatory pathways. The overall goal of the proposed research is to develop a mechanistic understanding of activation and modulation of α7 receptors applicable to therapeutic drug design. This proposal will investigate how calcium potentiates α7 nicotinic receptors activated by the low agonist concentrations that prevail physiologically. We have developed a co- agonist hypothesis that not only can explain how α7 signals despite being far from cholinergic nerve terminals, but it also suggests calcium fluctuations associated with neuronal firing regulate α7 signaling. To investigate calcium potentiation of α7, X-ray crystallographic methods will be used to determine atomic resolution structures of an α7 ligand binding domain bound with the potentiating ions calcium and barium. In parallel, single molecule electrophysiological methods will define the kinetic mechanism behind divalent ion potentiation. Finally, application of molecular biological and single molecule electrophysiological methods will identify amino acid residues in α7 that mediate divalent cation potentiation, and determine the stoichiometry with which divalent cations potentiate. Completion of this project will reveal mechanistic underpinnings of activation and calcium regulation of α7 applicable to neurological disease treatment and therapeutic drug design.

Public health relevance
PROJECT NARRATIVE- 7 nicotinic receptors mediate inter-cellular signaling in neuronal and non- neuronal cells, and are implicated in Alzheimer’s and Parkinson’s diseases, schizophrenia, attention deficit and inflammatory diseases including sepsis and asthma. This project will determine biophysical and structural mechanisms by which 7 nicotinic receptors mediate inter-cellular signaling and how the physiological modulator calcium controls its function. The results will lay the foundation for rational treatment of neurological and inflammatory diseases and development of therapeutic drugs.